ENBA2 in the pathogenesis of Sjogren's Syndrome

Sjögren's syndrome is a chronic, rheumatic, autoimmune disease that is characterized by a lymphocytic infiltrate of the exocrine glands as well as autoantibodies in the serum (anti-Ro/La or anti-SSA/SSB). Salivary and lacrimal gland dysfunction leads to severe dry eyes and dry mouth (sicca) in almost all patients, while some also have systemic (extra-glandular) manifestations that can involve the skin, lungs, kidneys, peripheral nervous system, muscles, CNS or joints. There is no known effective disease-modifying therapy, so treatment is symptomatic. Pathogenesis of the disease is poorly understood but involves a genetic risk as well as environmental factors. Epstein Barr virus (EBV), a near ubiquitous human infection, has been implicated in Sjögren's syndrome by several lines of evidence but a mechanism by which EBV might mediate pathogenesis has not been demonstrated. A recent study found that Epstein Barr nuclear antigen 2 (EBNA2), a viral transcription factor, preferentially binds genetics intervals containing a risk gene for systemic lupus erythematosus. This disease is highly related to Sjögren's, including a substantial overlap of the respective genetic associations. Binding to these lupus genomic areas was stronger when the interval contained the risk allele of the associated single nucleotide polymorphism. Thus, our central hypothesis is that EBNA2 expression and its binding of gene promoter regions containing Sjögren's-associated single nucleotide polymorphisms is a critical factor in the pathogenesis of Sjögren's syndrome. We will test this hypothesis by determining whether EBNA2 tends to bind genetic intervals with Sjögren's risk genes by use of novel search and analysis strategies. In addition we will determine whether EBNA2 is expressed more commonly in Sjögren's salivary glands compared to glands from subjects without Sjögren's syndrome. The second set of studies will use single cell transcriptome profiling from salivary gland frozen sections. This approach will find changes in gene expression associated with EBNA2 expression. Thus, we will leverage our repository of more than 1000 minor salivary gland biopsy specimens tied to extensive clinical and laboratory data for this project. This project also takes advantage of the opportunity afforded when studying Sjögren's to easily access the involved tissue; namely, salivary gland.

Public health relevance
Why Sjögren's syndrome develops is unknown, but the genes an individual possesses as well as environmental exposure are important. These studies will assess whether a protein (called EBNA2) from Epstein Barr virus, which infects also most everyone, interacts with genes increasing the risk of the disease. Such a gene-environment interaction may be important for development of the disease.